Corneal Biomechanics in Ocular Disease

ABSTRACT
The purpose of the proposed renewal is to add a longitudinal component for the purpose of
generating risk models to predict progression in ocular diseases that include biomechanical
metrics established at baseline. A novel metric of Corneal Contribution to Stress was
developed at baseline that represents long-term adaptation to asymmetric biomechanical
properties in keratoconus which we propose will predict progression over the follow-up period.
An additional metric of cornea compressibility will be included in the progression model. In
Diabetes without retinopathy, we propose that scleral stiffness will predict development of
diabetic retinopathy during the follow-up period, and that increased scleral stiffness is a
cumulative indicator of long-term hyperglycemia which we attribute to the formation of non-
enzymatic cross-links in the sclera. Hemoglobin A1c will be included in the model as a discrete
indicator of hyperglycemia. Finally, we propose to add elastic and viscoelastic biomechanical
metrics to the risk model from the Ocular Hypertension Treatment Study to predict the
conversion from ocular hypertension to glaucoma. Elastic parameters include corneal stiffness
and scleral stiffness, and the viscoelastic parameter is corneal hysteresis. Once completed,
these risk models can be translated to the clinic as new tools to aid in the management of
multiple ocular conditions.
.

Public health relevance
PROJECT NARRATIVE The proposed longitudinal research will result in the development of 3 models to predict risk of progression in ocular diseases with baseline biomechanical assessment. Progression models will include novel biomechanical parameters associated with asymmetry to predict progression in keratoconus, and scleral stiffness to predict the risk of developing diabetic retinopathy in diabetes. Biomechanical parameters will be added to the Ocular Hypertension Treatment Study risk model to augment prediction of conversion from ocular hypertension to glaucoma.